Developmental Funds

Developmental Funds represent the financial foundation of growth and development of the Center. In the next project period, we plan to use developmental funds to support collaborative pilot project awards, faculty recruitments, a developing resource (Proteomics), and 4 Staff Investigators.

Public health relevance
Developmental Funds represent the financial foundation of growth and development of the Center. CCSG funding is leveraged with other institutional sources to create a total investment pool toward new scientists, resources and research